Project 3:Optimal use of ART in establishing functional cures

PROJECT SUMMARY (Project 3 – Optimal use of ART in establishing functional cures)
In Project 3, Emmune, Inc. is collaborating with ViiV Healthcare to determine how antiretroviral therapy
(ART) should be administered so as to maximize the ability of AAV-expressed therapeutics to establish
robust functional cures and perhaps deplete the viral reservoir. ViiV Healthcare is developing long-
acting cabotegravir, a product with several potential synergies with AAV-expressed anti-retroviral
biologics developed by Emmune.
This program seeks to ‘functionally cure’ HIV patients with a one-time intramuscular injection of an
AAV-expressed therapeutic without the need for continuing antiretroviral therapy (ART). However,
when AAV is first administered, ART is probably necessary to prevent the emergence of resistant
viruses while the AAV-expressed therapeutic is present at suboptimal concentrations. Such resistance
has been observed when broadly neutralizing antibodies (bNAbs) were administered to patients. The
potential for resistance is an important reason why we have focused on eCD4-Ig, an immunoadhesin
constructed from an antibody Fc and the parts of CD4 and CCR5. Because it closely emulates these
HIV receptors, eCD4-Ig presents fundamental barriers to viral escape. Nonetheless, we have observed
the emergence of partial resistance to eCD4-Ig, albeit associated with a high fitness cost.
To prevent selection for partial resistance, we have pre-treated SHIV-infected macaques with ART
before administering AAV expressing eCD4-Ig. When ART was subsequently withdrawn, transient
‘blips’ of viral RNA were occasionally detectable. We hypothesize that the quality of these functional
cures can be improved by timing the application of ART so that host immune responses have not had
time to wane prior introducing AAV expressing eCD4-Ig. Thus, AAV-expressed eCD4-Ig and peak host
immune responses can work synergistically to deplete viral reservoirs and establish functional cures.
In this project, we will determine whether ART is detrimental to depleting viral reservoirs and
establishing functional cures in SHIV-infected macaques. To balance the need to prevent resistance
with the benefits of synergy with host immune responses, we propose initiating ART and AAV-
expressed eCD4-Ig at the same time. We also will determine whether a one-time administration of the
long-acting formulation of cabotegravir, at the same time as AAV-eCD4-Ig is administered, is a practical
solution for preventing partial resistance to eCD4-Ig. Conversely, we will also determine whether
expression of eCD4-Ig prevents cabotegravir resistance during its so-called ‘long tail’, when
cabotegravir concentrations are sub-clinical. Finally, these efforts will be supported by a panel of
immunological studies that will provide a mechanistic insight into how ART, eCD4-Ig and host immunity
collaborate to establish robust functional cures.